Predictability in complex object control

PROJECT SUMMARY
Manipulation of complex objects or tool use is a hallmark of daily living, and loss of manual dexterity due to motor
impairments lead to loss of independence. Manipulating objects is particularly challenging when the object has
internal dynamics that is not directly controlled. Even the seemingly simple task of transporting a cup of coffee
has intrinsic dynamics that humans need to predict, preempt, and compensate for to avoid spilling. Control of
such complex nonlinear systems with online error corrections based on precise internal models appears
daunting, given the slow neural processes and the ubiquitous noise in the sensorimotor system. Hence, this
research tests the hypothesis that humans learn to simplify the object interactions, i.e., make the interactions
predictable. The task of carrying a cup of coffee is modeled with a cart-and-pendulum system that is rendered
in a virtual environment and subjects interact with the virtual cup via a robotic manipulandum. To gain insight
into human control strategies, this proposal develops a task-dynamic approach that affords principled
hypothesis-testing by parsing the complex dynamics into execution and result variables, with minimal
assumptions about the human controller. Eight experiments test the overall hypothesis that humans seek
solutions that are predictable, by correlating hand-object motions, and making the behavior stable and tolerant
to error and risk to obviate error corrections and prevent failure. Aim-1 tests control of internal dynamics in linear
movements and examines how humans choose initial conditions to mitigate perturbations, how they preempt
undesired ball oscillations, how they exploit intermittent contact to develop a stable rhythm, and how they modify
the object properties to facilitate stable contact behavior. To examine learning, Aim-2 scales up the
dimensionality of the task by introducing more real-life planar cup movements, which creates an exponential
increase in complexity. Four experiments test task goals that introduce new dynamic challenges, such as
combination of rhythmic and discrete movements, complex ball dynamics when changing movement directions,
adaptation and modification of object properties, all to show how humans either exploit or override internal
dynamics to achieve predictability. Aim-3 introduces a real version of the task with a custom-designed device,
the MAGIC Table. Following a comparison of the real and virtual set-ups, the MAGIC Table is used to leverage
the theoretical framework to create novel sensitive metrics to quantify motor function for clinical applications.
Specifically, we assess severity and recovery of motor impairment in a cohort of patients after stroke. As manual
dexterity is compromised in many individuals with neurological disorders, the experimental paradigm and its
quantitative analyses promise to become a useful platform to gain insights into neurological diseases.

Public health relevance
NARRATIVE Interactions with complex objects such as carrying a cup filled with coffee are ubiquitous in daily life and essential for maintaining independence. Dexterous handling of objects is challenging as they create complex interaction forces that humans need to predict, preempt, and compensate for. Implementing the task of “carrying a cup of coffee” in virtual and real environments, we examine both healthy and neurologically impaired individuals to test the hypothesis that humans achieve dexterity by simplifying these interactions, i.e., by making them predictable.